Influences of DNA sequence and histone features on transcription factor binding to nucleosomes

Abstract
Gene expression programs are dynamically regulated by the accessibility of chromatin for
transcription factor (TF) binding, but how TFs recognize specific regulatory regions occluded by
nucleosomes remains unclear. Certain TFs, termed pioneer factors, can recognize their target
sites within nucleosomes, leading to the opening of chromatin. By priming cis-regulatory
elements for subsequent transcriptional regulatory activity, pioneers serve as gatekeepers to
cellular differentiation. Although pioneers can bind nucleosomal sites, they bind only a subset of
their potential recognition sites in the genome that typically varies across cell types, thus
indicating their interplay with sequence, epigenetic or other cellular features.
Despite the importance of pioneer factors, what restricts pioneer binding is poorly understood.
Little is known about how the sequence context of their sites in nucleosomes, the presence of
histone variants or post-translational modifications (PTMs) of histones, or interactions with
cofactors or chromatin readers that recognize those PTMs might influence pioneer binding to
nucleosomes. No high-throughput technologies have been developed to survey the impact of
these many parameters on TF pioneer binding.
In this project, we will develop novel, high-throughput biochemical assays to investigate how
nucleosomal sequence context, histone variants or histone PTMs influence pioneer binding of
human TFs to nucleosomes. We will also investigate the interplay of pioneers, cofactors, and
chromatin readers in pioneer binding. Results from these biochemical assays will be validated in
vitro and used in analysis of in vivo genomic data in human cells to understand how these
various features contribute to TF pioneer binding in cells.
As pioneer factors play crucial roles at the top of regulatory hierarchies, these results will aid in
understanding how gene regulation of cell states is encoded in the genome and the
mechanisms by which it is read out.

Public health relevance
Narrative Cell fate programs are initiated by ‘pioneer factors’ that recognize their genomic target sites within the context of nucleosomes and induce gene regulatory programs. We will develop technologies to investigate the influence of genomic sequence features and histone marks on the interactions of human pioneer factors with nucleosomes.